Preparedness for Caregiving in Experienced Caregivers of Persons Living with Dementia

Candidate: Dr. Emily Mroz is a postdoctoral fellow in Geriatrics at Yale School of Medicine. Having observed
unmet needs of family caregivers of persons living with dementia (PLWD) through her scholarship, training,
and lived experiences, her career goal is to develop resources to bolster psychological and behavioral
outcomes of family caregivers of PLWD. She plans to do this in an academic research setting, where she can
use her expertise to support a new generation of researchers and public health workers. Through her training
to date, Dr. Mroz has identified a uniquely underserved group of caregivers, has led multiple small research
studies with caregivers of PLWD, and has employed techniques to examine narratives of lived experiences.
Additional training will provide her with skills in a) psychometrics and measure validation, b) translating Stage 0
findings to design user-centered interventions, and c) leading larger, clinical trial research in collaboration with
engaged community partners. This training, combined with completion of the proposed research, will provide
critical support for Dr. Mroz’s junior faculty career transition. Project: Half of US family caregivers (> 11 million
adults) support PLWD, and many care for more than one PLWD across their adulthood. Promoting caregiver
preparedness improves psychological, behavioral, and quality-of-life outcomes for caregivers and PLWD and
reduced PLWD institutionalization. Current caregivers who have also previously provided care for a PLWD
(i.e., experienced caregivers) have developed skills that critically prepare them to navigate current care roles.
However, many experienced caregivers report low confidence in their caregiving abilities, as well as poor
psychological health, undermining their skills-based preparedness and thus their capacity to provide quality
care. Existing interventions have focused on caregiving skills, creating a resource gap for the growing
subgroup of experienced caregivers for which skills-based training is insufficient. This project will provide Stage
0 evidence for development of an intervention to improve preparedness (primary outcome) and psychological
health (secondary outcomes) in experienced caregivers. The central hypothesis is that experienced caregivers’
recall of subjective accounts from their earlier caregiving roles (i.e., caregiving narration) influences their
current preparedness, indicating the utility of a narrative-based intervention. To test this hypothesis, Dr. Mroz
will address three aims in a samples of experienced caregivers of PLWD: 1) validate a multidimensional,
questionnaire-based self-report measure of dementia-caregiver preparedness for identifying intervention end-
users, 2) characterize caregiving narration patterns according to salient narrative variables, indicating potent
and malleable mechanisms to engage during intervention development, and 3) identify associations between
narration variables and preparedness, exploring mediating effects of psychological health. On completion of
these aims, Dr. Mroz will have made necessary Stage 0 discoveries to support Stage 1 development of a user-
centered, narrative-based intervention, which she will pursue through an R01 proposal.

Public health relevance
NARRATIVE While dementia-caregiving can offer opportunities to learn caregiving skills, experienced caregivers often report low confidence and poor psychological health, diminishing their preparedness for new caregiving roles. Dr. Mroz aims to develop and validate a multidimensional measure of caregiver preparedness and use a narrative identity theoretical framework to determine associations between narratives from former caregiving roles, current caregiver preparedness, and other psychological health outcomes in experienced caregivers of persons living with dementia. Her long-term goal is to use the validated measure and quantitative findings to create a narrative-based intervention that supports experienced caregivers’ preparedness for current care roles while improving their psychological health outcomes.